Mechanisms of histone crosstalk with bacterial pathogens

PROJECT SUMMARY
Bacterial pathogens modulate the physiology of human cells by secreting effector proteins that assist pathogen
immune evasion and proliferation. The diverse repertoire of secreted pathogenic effectors re-wire an array of
cellular signaling pathways that are at the core of host cell function. One class of these effector proteins enter
the human cell nucleus and directly modulate transcriptional programs of the host by altering our epigenetic
code. These so-called epigenetic “nucleomodulins” represent an important aspect of host-pathogen interaction,
however very little is understood about how these effectors might interact with and sense the epigenetic
landscape of the host cell during infection. One of the most well-studied epigenetic nucleomodulins is RomA, a
histone lysine methyltransferase from Legionella pneumophila, the causative agent of Legionnaires Disease.
RomA mono-, di- and tri-methylates histone H3K14, silences the expression of host cell immune response
genes and enables efficient replication of L. pneumophila inside the host cytoplasm. RomA contains several
domains that are conserved in eukaryotic chromatin-binding proteins, suggesting that its H3K14 methylation
activity may be regulated by interacting with histone modifications of the host. In eukaryotes, the phenomenon
where an existing histone modification controls the recognition or deposition of another is called histone
modification crosstalk. These histone crosstalk mechanisms underlie the complex regulation of transcription
and genome architecture in eukaryotes. However, there are no known examples of a bacterial pathogen that
can interpret human histone modifications through histone crosstalk and alter the human epigenome. Such an
observation would greatly expand our understanding of host-pathogen interactions during infection. In this R21
proposal, we will use the L. pneumophila effector RomA as a model to establish if pathogenic bacteria can
interact with and interpret existing histone modifications through crosstalk mechanisms. In Aim 1, we will
subject RomA and individual RomA domains to a comprehensive three-part screen to establish if any human
histone modifications can bind to RomA or regulate its catalytic activity. Then, in Aim 2 we will establish a cryo-
EM screening workflow to identify optimal substrates and freezing conditions that will be necessary to
determine a structure of RomA bound to its preferred substrate nucleosome.

Public health relevance
PROJECT NARRATIVE Bacterial pathogens secrete effector proteins that modulate host cell physiology and enable the bacterial invader to escape immune detection and proliferate. One class of effectors re-wire our epigenetic signaling pathways by directly modifying histone proteins, but it is not known if these bacterial effectors can also be regulated by existing histone modifications in the human host. We will use the L. pneumophila effector RomA as a model to establish if pathogenic bacteria can interact with and interpret existing histone modifications through crosstalk mechanisms.